Sensing and manipulating biological systems with quantum photonic technologies.

Project Summary/Abstract
From everyday clinical practice to fundamental research, the biomedical field is in constant need of accurate
measurement technologies. Moreover, non-destructive manipulation of live biological systems has been the
aspiration of biomedical scientists. Recent progress in quantum information science, especially in the
development of quantum optics and sensing techniques, provides enticing opportunities for biomedical sciences.
When quantum mechanical principles like superposition and entanglement are applied to light-matter interactions
at extremely small length scales, on the order of single molecules and atomic bonds, unparalleled precision and
accuracy can be introduced to biological systems. However, practical implementations of quantum metrology in
the biomedical field are usually hindered by their low efficiency and demanding environmental conditions.
Dr. Yesilkoy’s research focuses on the development of nanophotonic devices that can manipulate light at the
nanoscale beyond the diffraction limit and enhance light-matter interactions. The lab’s approach is key to
satisfying the demanding requirements of quantum metrology and enabling its practical applications in the
biomedical field. Specifically, in this research program, Dr. Yesilkoy’s team will work on the following two thrusts:
Thrust 1: Quantum biochemistry to manipulate intracellular processes: Noninvasive regulation of
intracellular chemical processes, such as gene expression, protein, and metabolic pathway, is critical in
biomedical sciences. Here, Dr. Yesilkoy’s lab will implement the powerful photonic cavities generated by our
nanophotonic devices to achieve vibrational strong coupling, underpinned by the entanglement of infrared cavity
resonance and biomolecules’ quantum stares. Her team will demonstrate regulation over kinase activities in live
cells.
Thrust 2: Quantum-enhanced nanophotonic biosensors: Biomolecular sensors capable of detecting
biomarkers at the single molecule level can provide high accuracy, sensitivity, and real-time detection
capabilities, which are urgently needed for early disease diagnosis, personalized medicine, drug development,
and fundamental biomedical research. Here, Dr. Yesilkoy and her team will combine the precision of quantum
metrology with powerful nanophotonic sensors to reach single molecule detection limits in complex biological
samples.
The proposed technologies are significant for biomedicine because 1) ultrasensitive label-free biomarker
detection beyond the detection limits of commercially available assays (<10-12M) can enable early detection of
cancer and make population screening initiatives more effective. 2) non-destructive control over intracellular
processes can lead to groundbreaking opportunities in biomanufacturing of biological drugs and cell therapies.

Public health relevance
Project Narrative Quantum metrology is characterized by unprecedented precision and accuracy in measurement science, offering critical opportunities to advance biomedical research and clinical practice. By harnessing quantum principles, including entanglement and coherent light-matter interactions, this project seeks to develop highly sensitive molecular detection technologies and novel strategies to regulate intracellular biochemical processes. These innovative approaches promise to significantly improve the accuracy of early disease detection, efficacy of personalized therapies and advance cell and biological drug manufacturing.